Early determinants of childhood obesity: Etiology disparities policy analysis

Project Summary By age 5, more than 10% of US children are obese and children from ethnic minority groups and more disadvantaged circumstances are disproportionately affected. While evidence exists that risk factors during pregnancy and early life are associated with childhood obesity, potential confounding in observational studies and small, restricted samples present challenges to infer causation. There is debate about the extent to which these relationships apply to all racial/ethnic groups. Policies enacted to support healthy behaviors may actually increase disparities in the risk factors for obesity if they are adopted only by mothers from certain racial/ethnic groups or more advantaged groups. Few studies have addressed this concern. This K99/R00 award will provide an opportunity for the PI to build on her background in epidemiology and acquire training in causal inference, policy evaluation, and translating research into policy through formal courses and mentorship by an interdisciplinary group of renowned scholars. The overarching goals of this K award are to clarify peri- and post-natal risk factors for disparities in childhood obesity and to examine the effects of policies on disparities in these risk factors. This program of research will move forward the field of obesity prevention by maximizing the utility of public data through data linkage, integrating analytic techniques from economics and epidemiology to infer causality, understanding influences on racial/ethnic and socioeconomic disparities, and identifying policy drivers for behavior change. The PI will create a dataset of 215,000 children by linking Massachusetts birth certificate data to an electronic database of well-child visits. During the mentored phase of the award (K99), the PI will examine disparities in maternal smoking during pregnancy, excessive gestational weight gain, and breastfeeding as well as examine the associations between these risk factors and adiposity-related outcomes at ages 2 and 5 years. During the independent phase of the award (R00), the PI will examine the influence of policies on the prevalence and racial/ethnic and socioeconomic disparities in these risk factors, focusing on recent changes in tobacco control policies and gestational weight gain recommendations. Policies and programs for early childhood obesity prevention both in Massachusetts and nationally will be assessed to determine the extent to which factors during pregnancy and early life are included. The PI will present the findings from this program of research to policy makers in state government and help identify areas for future obesity prevention strategies. The PI will submit an R01 application during the fourth year of the award to continue to pursue these methods and interdisciplinary collaborations with the aim of pushing forward the research agenda on disparities in maternal and child health.

Public health relevance
Project Narrative The aims of the program of research in this K99/R00 award are to address racial/ethnic and socioeconomic differences in perinatal and postnatal risk factors for childhood obesity and identify policy drivers for behavior change. The results will be presented to policy makers in state government to help identify areas for future obesity prevention strategies. __SpecificAimsTextDelimiter__ 10. Specific Aims With approximately 10% of 2- to 5-year-olds classified as obese,31 even preschool children have not been spared. Children from ethnic minority groups and more disadvantaged circumstances are being disproportionately affected by the obesity epidemic.32, 33 Lifecourse epidemiology proposes that factors during pre- and post-natal periods may influence health outcomes from early life through adulthood.34 Research has found direct associations of maternal smoking during pregnancy9, 35 and excessive gestational weight gain36 with childhood obesity, but an inverse association with breastfeeding duration.37-39 This suggests that modifying risk factors during pregnancy and early life may be critical in obesity prevention.13, 40, 41 The evidence base has relied primarily on observational studies limiting the ability to infer causation because of potential confounding and lack of an experimental design. Sibling pair designs can overcome some of these limitations.42 Most studies also have been conducted in small, restricted samples which have hindered the understanding of social gradients in obesity. Policies enacted to support healthy behaviors may actually increase disparities in the risk factors for obesity if they are adopted only by mothers from certain racial/ethnic groups or more advantaged groups.43 Few studies have addressed this concern. Natural experiments created through changes in policies can be assessed by integrating analytic techniques from epidemiology and economics to help infer causality and examine the impact of policies on racial/ethnic and socioeconomic disparities. The overarching goals of this K99/R00 award are to clarify peri- and post-natal risk factors for disparities in childhood obesity and to examine the effects of policies on disparities in these risk factors. I will create a dataset of 215,000 children by linking Massachusetts birth certificates to an electronic database of well-child visits. During the mentored phase of the K award the research objectives are: 1) To examine disparities in the risk factors for obesity and adiposity-related outcomes as well as examine the associations between risk factors and adiposity-related outcomes at ages 2 and 5 years. The specific aims are: a) To examine racial/ethnic and socio-demographic predictors of maternal smoking during pregnancy, excessive gestational weight gain, and breastfeeding initiation and duration. b) To examine racial/ethnic and socioeconomic disparities in trends of childhood obesity (1980-2008). c) To examine the associations, separately, of maternal smoking during pregnancy, excessive gestational weight gain, and breastfeeding initiation and duration with adiposity-related outcomes; in addition, how these associations vary by race/ethnicity. d) To repeat analyses in Aim 1c using fixed effects models fit among siblings discordant on risk factors across pregnancies; in addition, how these associations vary by race/ethnicity. During the independent phase of the K award the research objectives are: 2) To examine the influence of policies on the risk factors for obesity and how policies may influence disparities in these risk factors. The specific aims are: a) To examine racial/ethnic and socioeconomic disparities in trends of maternal smoking during pregnancy (1987-2011) and excessive gestational weight gain (1980-2011). b) To assess the impact of changes in the Institute of Medicine guidelines for gestational weight gain in 1990 and 2009 on changes in gestational weight gain and disparities. c) To assess the impact of changes in tobacco control policies in Massachusetts, including cigarette tax increases and smoke-free legislation, on maternal smoking behaviors and disparities. d) To compare changes in smoking behaviors between mothers with Medicaid and private insurance before and after the 2006 Medicaid policy change, which allowed recipients access to free tobacco cessation medications and counseling. 3) To assess policies and programs for early childhood obesity prevention in Massachusetts and nationally. The specific aims are: a) To evaluate obesity prevention policies across state agencies in Massachusetts and the federal government to determine the extent to which factors during pregnancy and early life are included. b) To present the findings from this program of research to stakeholders at the Massachusetts Department of Public Health and to help identify areas for future obesity prevention strategies.